Assessment of speech- and fine-motor coordination and their link to language in children with autism spectrum disorder

PROJECT SUMMARY
Autism Spectrum Disorder (ASD) is a neurodevelopmental disorder associated with motor difficulties in speech
production and fine-motor tasks. Assessments of motor impairments, however, can be subjective and miss subtle
and specific abnormalities. Therefore, there is a need to develop objective measures for clinicians to assess and
understand speech- and fine-motor impairments in individuals with ASD. In addition, recent research suggests
that difficulties with speech production, fine-motor, and oculo-motor tasks may contribute to language difficulties
in ASD. The purpose of this project is to develop objective measures of speech- and fine-motor coordination in
children with ASD, and to characterize the relationship between motor modalities and expressive language in
ASD using these measures. We will focus on three speech subsystems: articulatory, laryngeal, and respiratory,
as well as handwriting and eye movement. In a pilot study we conducted at the Lurie Center for Autism, we
utilized novel coordination features developed in our lab to highlight lower complexity of coordination, or higher
coupling, between and within speech subsystems in highly verbal children with ASD as compared to neurotypical
controls. The analyses also indicated lower complexity of coordination during handwriting in children with ASD,
suggesting there may be similar underlying mechanisms across these motor systems. In the proposed project,
we will extend upon these promising results, evaluating measures of motor coordination using low-level features
derived from speech, handwriting, and eye movement tasks completed by children with ASD and neurotypical
controls. We will employ acoustic-to-articulatory inversion techniques to extract more physiologically accurate
vocal tract articulator movements and coordination. Aim 1 uses measures of coordination to characterize the
complexity of speech- and fine-motor coordination in children with ASD. We will also determine the features
which provide the highest discriminatory ability between children with ASD and neurotypical controls using
machine learning models. We expect that identification of patterns of complexity and important discriminatory
features will provide a better understanding of the dependencies across and within motor subsystems, which
could be used for objective assessment and tracking of motor difficulties in ASD. Aim 2 characterizes the
relationship between speech- and fine-motor skills and expressive language ability. We will evaluate correlations
and regressions between measures of motor coordination and scores on assessments of expressive language.
We believe that motor tasks and features which show high correlations with evaluations of language ability will
provide further insight into how motor modalities are associated with language difficulties in ASD. In summary,
this proposal aims to quantify and understand speech- and fine-motor coordination challenges in ASD using
objective measures of motor coordination, and aims to characterize the relationship between speech- and fine-
motor subsystems and expressive language in ASD. This project works towards our long-term goal of developing
a platform to assess, understand, and track motor and communication challenges in children with ASD.

Public health relevance
PROJECT NARRATIVE Autism Spectrum Disorder (ASD) affects 1 in 59 children in the United States. Children with ASD typically display challenges with speech- and fine-motor coordination, which have also been hypothesized to contribute to expressive language difficulties in this population. In this project, we aim to develop objective measures of motor coordination challenges across speech, handwriting, and eye movement tasks and aim to assess their relationship with clinical measures of expressive language in children with ASD.